Neural Mechanisms underlying dissociable effects of cTBS in Psychostimulant Abuse

ABSTRACT
Nicotine addiction is associated with deficits in prefrontal cortical (PFC) mediated control over inhibiting behavior
and regulating appetitive response. We have reported stimulation pattern-dependent dissociable modulatory
effects of low-frequency non-invasive brain stimulation (NIBS; cTBS) when applied to the lateral PFC—right
inferior frontal gyrus (r.IFG) on inhibitory control, corticolimbic resting state functional connectivity (rsF) and
smoking behavior. We further identified a novel pattern showing that dorsomedial PFC (preSMA) rsFC with
corticostriatal circuitry predicts regulation of craving efficacy and smoking lapse vulnerability, and that preSMA
NIBS modulates corticostriatal rsFC. Our preliminary findings, along with the extant literature also suggest PFC
location specific effects of continuous theta burst stimulation cTBS on changing the strength of cortico-limbic-
striatal functional connectivity (FC) and reducing the concentration of excitatory neurometabolites in the
respective circuitry target by cTBS. The goal of this proposal is to conduct a location control (vertex) crossover
study of cTBS to examine the neurocircuitry and neurobiological mechanisms mediating the effects of cTBS to
r.IFG and preSMA on inhibitory control and craving regulation, respectively, and evaluate associations between
neural outcomes and smoking behavior over the subsequent 24-hours.

Public health relevance
PROJECT NARRATIVE Despite recent advances in using non-invasive brain stimulation (NIBS) for treating nicotine dependence, there remains a relative dearth of knowledge guiding selection of cortical areas to target with NIBS for a specific disorder, the stimulation parameters that yield the most clinically relevant change in behavior, and the neurobiological mechanism that mediate the effects of NIBS on behavior. Based on our prior findings, the overarching goal of this proposal is to examine the neural mechanisms underlying the effects of continuous theta burst stimulation (cTBS) to the right inferior frontal gyrus and preSMA on addiction related behaviors.